Administrative

This core provides administrative support to the project. With the help of the Physiology and Pathology Department Administrators, Becky McGowan and Beth Pereira, the budget allocations and financial reporting requirements for all these projects are performed by this core. A one and one-half day retreat has been held in each year of funding (see program for 2009 in appendix). In addition a series of seminar speakers on aspects of the biology of the mammary gland are hosted each year. Importantly the retreat has allowed us to reach out to other investigators who were not part of the funded program and has provided additional collaborators, some of whom will play a major role in the next project period, particularly Drs. McLean, McCurdy (Project II, this proposal) and Jennifer Richer, new PI, Project III.